Cancer Heterogeneity, Immunity, and Microenvironment (CHIME) Training Program

PROJECT SUMMARY
This proposal requests renewed support for a robust and successful postdoctoral training program at the Salk
Institute. Under the guidance of a new leadership team, co-Directors Drs. Susan Kaech and Geoffrey Wahl have
renamed the Salk T32 Cancer Training Program the “Cancer Heterogeneity, Immunity, and Microenvironment
(CHIME) Training Program,” reflecting: 1) a revitalized program now focused on cancer heterogeneity (within
each tumor and across different cancer types and individuals), cancer immunity, and the tumor
microenvironment, 2) the evolving and diverse expertise of the T32 Program Faculty and members of Salk’s
NCI-designated Cancer Center, and 3) technologies now available in Salk’s Scientific Core Facilities that enable
researchers to attack cancer from these diverse vantage points. Major research interests of the Program Faculty
include cancer metabolism, immunology, autophagy, mitochondrial biology, genomic/epigenetic variability, and
computational biology, which coalesce into the two research programs of the Salk Cancer Center: Genetic,
Epigenetic & Immune Circuits, and Animal Models of Cancer & Therapeutics. The Salk Cancer Center includes
36 faculty members, 29 of whom are members of the T32 Program Faculty. There are ~160 postdoctoral trainees
in the Salk Cancer Center, representing a robust and highly qualified applicant pool. The overall goal of the T32
Training Program is to provide Fellows with the research training and career development opportunities that will
enable them to launch successful careers in cancer biology research. Training elements available exclusively to
T32 Fellows (i.e., those that add value to their training experience over other Salk trainees) include: 1) a Pulling
Back the Curtain Workshop – a partnership with the UCSD Moores Comprehensive Cancer Center that includes
meetings with oncologists and clinical researchers, as well as participation in Cancer Rounds and Molecular
Tumor Board Meetings, 2) a Tumor Heterogeneity Workshop delivered by Salk Core Directors and Faculty, 3)
the ability to present their research-in-progress annually in the Cancer Center Trainee Research Seminar Series,
4) Chalk Talk Tutorials, 5) opportunities to organize the yearly T32 Cancer Symposium, and 6) frequent
interactions with the co-Directors, the T32 Steering Committee, and the T32 External Advisory Board. Additional
career development opportunities include courses on Cancer Biology, Modern Drug Discovery, and Responsible
Conduct of Research, as well as workshops on Emerging Technologies, Grant Writing, Entering Mentoring, and
Rigor and Reproducibility. The Salk Postdoctoral Office also provides a wide range of career development
opportunities. This training program will support six postdoctoral trainees (PhD, MD/PhD, or MD) selected as
T32 Fellows based on the strength and cancer relevance of their research proposal, their prior achievements,
and an interview. Fellowships are for two years, with the potential for a third year if the Fellow demonstrates
progress and has applied for external support. This rigorous Training Program will equip each T32 Fellow with
the scientific and career skills necessary to establish themselves as successful, independent cancer researchers.

Public health relevance
PROJECT NARRATIVE The NCI-designated Basic Laboratory Cancer Center at the Salk Institute for Biological Studies provides a rich training environment for postdoctoral fellows as they advance their careers in cancer research. In addition to rigorous, hands-on training in experimental research provided by faculty mentors, the proposed T32 Cancer Heterogeneity, Immunity, and Microenvironment (CHIME) Training Program provides workshops in cutting-edge technologies, as well as exposure to local clinicians and the problems they face while treating patients. These training elements, together with an array of career development opportunities, provide a solid foundation on which Salk T32 Fellows can build independent, research-intensive careers to help move the field toward more durable and selective cancer therapies.